The Respiratory Microbiome in COVID-19: Associations with Severity, Risk Factors, and Host Pathways

COVID-19 has caused unprecedented loss of life and global disruption since its emergence in 2019. Caused
by the SARS CoV-2 virus, this infection shows extreme heterogeneity, ranging from completely asymptomatic
to deadly. One factor that has been linked to COVID-19 severity is the microbiome of the upper respiratory
tract, specifically the oropharynx. Lower relative abundance of oral commensal taxa, such as Haemophilus,
Neisseria, Prevotella, and Actinomyces, and lower alpha diversity are seen in severe COVID-19 patients
compared to individuals with more moderate disease. The mechanism of this association is still unknown, and
it is unclear in which direction causation occurs. We propose to further examine the association between the
respiratory microbiome and COVID-19 by 1) increasing specificity of these associations to the species, strain,
and gene level, 2) identifying how comorbidities shape the respiratory microbiome prior to SARS CoV-2
infection, and 3) identifying host pathways that may be involved in these associations. For this first aim, we will
leverage a cohort of over 200 hospitalized COVID-19 patients (previously enrolled and specimens already in
hand), using deep metagenomic sequencing for taxonomic and functional annotation. The increased specificity
provided by this aim will pave the way for in vitro or animal model experiments, which require species or strain
level associations for proper experimental design. The second aim will focus on respiratory tract microbiome
profiles in individuals with obesity, diabetes, or old age (who do not and have not had COVID-19), three
conditions that are strongly associated with elevated risk of severe COVID-19. The effect that these have on
the respiratory microbiome is unknown, but one still untested possibility is that the microbiome mediates some
of the effects of these conditions on disease severity. By studying microbiome alterations in these diseases
prior to SARS CoV-2 infection we could identify a potential high risk microbiome that precedes severe COVID-
19. Finally, the third aim pulls data from a diverse set of databases to create a knowledge graph of microbe-
disease-gene associations. Using knowledge graph completion, we will predict host genes that both associate
with COVID-19 severity, and interact with bacteria in the upper airway. With this data, we can propose possible
host mechanisms that mediate microbiome-COVID-19 associations, allowing for in vitro follow-up to move from
correlation to causation. Ultimately, this work is a bridge between existing high level associations between
COVID-19 and the upper respiratory microbiome, and future work targeting specific mechanisms and causal
links. Having recently published a review on all studies of the airway microbiome in COVID-19, we believe that
these aims address the most critical gaps in understanding currently in the literature.

Public health relevance
COVID-19 is characterized by heterogenous symptoms and outcomes, and identifying what factors determine disease severity is a top priority. The airway microbiome has emerged as a differentiating factor, with a less diverse, dysbiotic microbiome found early in more severe disease. This work aims to carry these associations to the species level, understand how comorbidities influence the microbiome, and leverage advanced machine learning to start identifying potential microbe-host interaction mechanisms.